Multiparametric transrectal ultrasound and photoacoustic imaging of human prostate

ABSTRACT
Prostate cancer (PCa), with an annually increasing incident rate, has become the most commonly diagnosed
cancer in American men. The accurate diagnosis of aggressive PCa is critical for the survival of patients.
Transrectal ultrasound (TRUS) guided biopsy, the current standard procedure for evaluating the presence and
aggressiveness of PCa, suffers from low core yield, leading to under-sampling and under-grading of clinically
significant tumors. To fill the long-standing technical gap in PCa diagnosis, we propose to develop a novel
multimodal imaging platform which integrates the emerging photoacoustic (PA) imaging technique with the
established transrectal ultrasound (TRUS) for multiparametric PCa diagnosis and grading. With the unique
capability to map structural/anatomical, mechanical, functional, and molecular information reflecting pathological
conditions over the entire human prostate in vivo, non-invasively, the proposed TRUS and PA (i.e. TRUSPA)
multiparametric imaging can sensitively detect spatially distributed prostate tumors and, more importantly,
differentiate aggressive tumors from non-aggressive ones. Hence, multiparametric TRUSPA (mpTRUSPA),
when performed in the same way as in current TRUS, could largely improve the guidance of biopsy sampling by
ensuring highly effective core extraction within the most aggressive malignant regions of the prostate.
The central hypothesis is that real-time mpTRUSPA imaging – displaying B-mode US based structural
information, Power Doppler US based vascular flow, shear wave elastography (SWE) based tissue stiffness,
and spectral PA images for mapping hypoxia and angiogenesis - can sensitively characterize cancer
aggressiveness in vivo by mapping a group of structural, mechanical, and functional biomarkers of PCa, and
can subsequently guide the biopsy sampling. This hypothesis will be objectively and rigorously examined via the
proposed studies on clinically relevant PCa animal models and human subjects using the following specific aims:
Aim 1: Develop and validate mpTRUSPA imaging system using studies on durable prostate mimicking phantoms
and mouse models of aggressive and non-aggressive PCa. Aim 2: Develop and validate an artificial intelligence
(AI) framework capable of signal denoising and localization, prostate segmentation, artifact correction, and
spectral unmixing of deep tissue PAI signals in real-time. Aim 3: Validate a set of PCa imaging biomarkers that
are accessible in vivo by the AI enhanced mpTRUSPA imaging system in a clinical setting.
Once the performance of mpTRUSPA imaging of PCa is validated via the proposed studies on animal models
and human subjects, this affordable and user-friendly technology will be ready for appropriate phase I/II clinical
trials in the next funding cycle. TRUSPA, with the unique capability of detecting and differentiating clinically
significant PCa non-invasively, in real time, can seamlessly fit into the current clinical procedure of image-guided
biopsy, and holds great potential to shift the paradigm of PCa diagnosis.

Public health relevance
PROJECT NARRATIVE Proposed novel multiparametric transrectal ultrasound and photoacoustic imaging platform, with unique capabilities to map structural, functional, mechanical, and molecular information reflecting pathological conditions of human prostate in vivo, will likely help differentiate aggressive from non-aggressive prostate cancer.